Quality Improvement Summit on Opportunities to Improve Palliative Care in Urology

Project Summary/Abstract: Opportunities to Improve Palliative Care in Urology The American Urological Association (AUA) is requesting an AHRQ Conference Grant to support convening a Quality Improvement Summit on Improving Use of Palliative Care in Urology, with discussion focusing on: management of the disease course of individuals with advanced benign and malignant urologic diseases, identification of the aspects of palliative care services that may be offered in a urology practice, overview of current palliative care workforce, and the development of a health services and educational agenda that advances urologist-palliative care partnerships. The AUA’s Quality Improvement Summits address quality issues, define clinical problems, facilitate information exchange on quality efforts by clinicians across disciplines and care settings, and educate urology practitioners, primary care physicians, and specialists about developing patient-centered quality improvement programs. For its 2020 summit, the AUA will convene a multi- disciplinary panel of speakers to take part in a collaborative effort dedicated to addressing the palliative care needs of patients with advanced urological health conditions. The 2020 Summit will provide a unique and timely opportunity to accelerate the application of evidence into practice by bringing together physicians, researchers, and professional societies spanning the disciplines of urology, palliative care, other surgical specialties, psychiatry, and pain management around the shared goal of improving care delivery as it relates to the intersection of urology and palliative care. Our specific aims: Aim 1. To review the experiences of urologists and palliative care clinicians in managing the disease course of individuals with advanced benign and malignant urologic diseases. This will include assessments of the settings in which goals of care, prognosis, diagnosis, advance care planning, goals of operations and procedures, and physical and psychological symptom management are currently being pursued. Aim 2. To summarize and consolidate current data related to what aspects of care are most important to improve quality in individuals with advanced urologic conditions. Aim 3. To define current palliative care capacity, and aspects of palliative care that could be provided by urologists in a mixed-model setting. Aim 4. To create a health services research, policy, and dissemination agenda that advances urologist- palliative care partnerships to ensure that all aspects of care are adequately addressed in those with advanced disease. Aim 5. To build a national interdisciplinary implementation partnership to implement best practices agreed upon at the summit. Through the completion of these aims, we will better understand the gaps in care for urologists caring for advanced urological health conditions and work to construct an educational and clinical quality improvement implementation strategy to improve the care of men and women with advanced urological health conditions.

Public health relevance
Project Narrative: Opportunities to Improve Palliative Care in Urology The United States is faced with the growing public health challenge of treating patients with end- of-life health conditions which has substantially contributed to the inexorably rising costs of health care. Sources of excessive expenditures at the end of life include overuse of aggressive treatments unlikely to extend length of life, intensive care unit admissions, emergency room admissions, and other hospital services that may be avoided through early implementation of palliative care services. Early consultation with palliative care is associated with improved quality of life at the end of life, and has been associated with improved quantity of life for certain diagnoses such as advanced cancer. In this context, the American Urological Association (AUA) is working to increase awareness of this issue and provide its members nationwide with an evidence-based action plan to reduce the burden and optimize value of care for those with advanced urological health conditions. As a foundational step, the AUA is convening a multi- stakeholder Quality Improvement Summit to address this topic, bringing together experts from urology, palliative care, broader surgical specialties, psychiatry, and pain management to discuss a variety of topics including: management of the disease course of individuals with advanced benign and malignant urologic diseases, identification of the aspects of palliative care services that may be offered in a urology practice, overview of current palliative care workforce, and the development of a health services and educational agenda that advances urologist- palliative care partnerships.